Daily Memory Lapses and Sympathetic-Cardiovascular Dysfunction: Pathways to Prevention of Alzheimer's Disease and Related Dementias (ADRD)

PROJECT SUMMARY
The current project will examine whether and how negative affective responsivity to daily memory lapses is
related to sympathetic-cardiovascular dysfunction in young, healthy adults. Daily memory lapses are a
common, everyday experience that cause emotional distress among some adults regardless of age. Our
previous work demonstrates that this emotional distress is heightened among young adults and persists even
after accounting for other types of daily stress experiences (e.g., arguments or work stressors). Given that
emotional distress in response to stressors is associated with a number of physical, emotional, and cognitive
health consequences, it is critical to identify the physiological pathways that link daily experiences of emotional
distress like negative affective responsivity to broader cardiovascular functioning. Further, as individuals higher
in depressive symptoms are more likely to experience negative affective responsivity and cardiovascular
dysfunction, depressive symptoms are a key individual difference factor that may make individuals more
vulnerable to these pathways. This secondary data analysis aims to daily diary assessments of memory lapses
and their impacts on daily emotions to direct lab-based assessments of micro-vascular functioning. We will use
multilevel structural equation modeling to examine three primary aims: 1) examine how frequency of daily
memory lapses relates to sympathetic-cardiovascular dysfunction; 2) examine how negative affective
responsivity to daily memory lapses relates to sympathetic-cardiovascular dysfunction; and 3) determine
whether level of depressive symptoms moderates these relations. This application combines innovative
approaches that allow more precise measurement of both the experience of daily problems with memory and
the physiological processes responsible for a wide range of health conditions including hypertension, major
depressive disorder, and eventually Alzheimer’s disease. This work capitalizes on previously collected data to
efficiently generate new research that will help identify intervention targets for the promotion of healthier
cognitive aging that can be implemented earlier in the life span to prevent cognitive decline.

Public health relevance
PROJECT NARRATIVE The current proposal will examine how daily memory lapses and responses to daily memory lapses relate to sympathetic-cardiovascular dysfunction. Using cutting-edge assessment techniques, we will combine daily memory lapses measured via daily diaries with lab-based measures of direct micro-vascular functioning and reactivity. Results promise to enhance interventions that mitigate the impacts of daily experiences on physical, emotional, and cognitive health.